CE19-001, University of Michigan Injury Prevention Center 2019-2024

U-M Injury Prevention Center Abstract
The University of Michigan Injury Prevention Center is a comprehensive ICRC that integrates all phases
of injury prevention and control across the spectrum of age groups. The Center is supplemented by the
vast educational, research, outreach, and policy resources of the University of Michigan (U-M), whose
injury faculty and practitioners are ready to address the burden of injury in Michigan, across the Great
Lakes Region (including the states of Illinois, Indiana, Ohio, and Wisconsin), and be a resource nationally.
The Center has a decade of experience in conducting injury prevention research, outreach and
translation, as well as educating the next generation of injury scientists and practitioners. The mission of
the Center is to conduct high-quality research and training, to translate and accelerate research and
scientific discoveries into practice and policy, and to reduce injuries and violence within the Great Lakes
Region and across the US.
The proposed Center is organized around four multidisciplinary cores (Administrative, Outreach & Translation
with a Policy Workgroup, Training & Education, and Research with a Statistics & Methods Section) and four
research projects. Our center provides the infrastructure to coordinate a collaborative injury prevention
agenda focused on the prevention of opioid overdose, suicide, youth/sexual violence, concussion, motor
vehicle crash, and an emerging portfolio in older adult falls. Adverse childhood experiences are a
crosscutting and underlying risk factor addressed for all of our focus areas.
The Center will continue teaching and mentoring undergraduate, graduate, and postdoctoral students, as well
as junior faculty across disciplines, including medicine, public health, behavioral and social sciences,
biostatistics, biomechanics, epidemiology, law, criminal justice, nursing, kinesiology, and policy. We will
provide outreach, technical assistance, and consultation on translating research into practice through
supporting relationships with state health departments as well as local researchers and practitioners. The
Center supports the Midwest Injury Prevention Alliance, serves on The Society for Advancement of Violence
and Injury Research Council of Centers, and provides the framework for a coordinated, collaborative injury
prevention agenda serving the Great Lakes Region with active reach throughout the United States.

Public health relevance
U-M Injury Prevention Center Narrative The mission of the University of Michigan Injury Prevention Center is to conduct, translate, and accelerate high-quality injury research and training into practice and policy to reduce the burden of injuries and violence across the Great Lakes Region, and throughout the United States.